Dose escalation clinical trial of high-dose oral montelukast to inform future RCT in children with acute asthma exacerbations

PROJECT SUMMARY
The goal of this R34 proposal and the future R61/R33-funded RCT is to decrease the severity of moderate and
severe acute asthma exacerbations in children, sufficiently and quickly enough to decrease hospitalizations.
These hospitalizations disproportionately affect Black and low-income children. They often occur because leu-
kotriene (LT) induced airway inflammation and bronchoconstriction are incompletely responsive to systemic
corticosteroid (CCS) and inhaled albuterol. LT synthesis is induced by viral respiratory infections and aeroaller-
gens, the most common exacerbation triggers in children. We have a critical clinical need for a medication that
will rapidly decrease LT-mediated airway inflammation and bronchoconstriction. Montelukast (MK), a potent
LT-receptor antagonist, may address this need. IV MK caused rapid, sustained improvement at peak plasma
levels (Cmax) of ≈1,700 ng/ml in adults with moderate and severe exacerbations. IV MK is not available, and
our preliminary pharmacokinetic (PK) study in children with exacerbations found that high-dose oral MK (mean
1.0 mg/kg) achieves Cmax of 1,700 ng/ml in 40% of participants. The R34 Aim is to perform an adaptive, PK-
guided, double-masked RCT of standard treatment plus high-dose oral MK or identical placebo, with 3 escalat-
ing mg/kg MK dose-levels determined by PK-guided dose modeling, in children with exacerbations that are
moderate or severe after initial treatment with albuterol. We will test three Hypotheses (1) High-dose oral
montelukast achieves Cmax >1,700 ng/ml in >86% of at least one of three sequential participant groups with
escalating weight-based (mg/kg) doses between groups; (2) Participants randomized to high-dose oral monte-
lukast have a 2 point or greater improvement of the validated Acute Asthma Intensity Research Score (AAIRS)
4 hours post-treatment in comparison with control group participants; and (3) Among montelukast recipients,
Cmax correlates with change of the AAIRS at 4 hours. This R34 research will yield essential and sufficient
knowledge to make definitive design decisions for a Phase II RCT (R61-R33 funded), adequately powered for
important clinical outcomes. The future RCT will test the hypothesis that the optimal mg/kg MK dose identified
in this R34 research improves outcomes as an additional anti-inflammatory and bronchodilator medication in
children with moderate and severe exacerbations. The overall Contribution of this research will be to identify an
optimal mg/kg dose of oral MK for the future RCT. The Significance of this R34 research and of the future RCT
is that high-dose oral montelukast will provide a critically needed medication for exacerbations to decrease the
morbidity of this common illness. This research is Innovative by (1) Identifying an optimal mg/kg dose for the
future RCT; (2) Providing preliminary efficacy and dose-response data; and (3) Repurposing an inexpensive
drug in a novel way to address an unmet need in children with asthma exacerbations. Completion of this re-
search will yield knowledge to decrease the morbidity and health burden of asthma exacerbations in children.

Public health relevance
PROJECT NARRATIVE AND RELEVANCE The proposed R34 and future R61-R33 research are relevant to public health because they focus on repurposing a safe, inexpensive, anti-inflammatory medicine (oral montelukast) to decrease hospitalizations of children with acute asthma exacerbations. This research may lead to more effective and personalized treatment for these children by selectively augmenting or replacing systemic corticosteroid, the only anti- inflammatory medicine currently available and one with concerning side effects. Thus, the proposed research is relevant to the NHLBI mission to promote treatment of lung disease and enhance the health of individuals to live longer and more fulfilling lives.